Identifying small molecules with selective toxicity towards muscle invasive prostate cancer cells

This project team aims to screen and develop chemical probes with differential drug sensitivity profiles of a muscle-invasive prostate cancer cell line.

During this period, the team continued to characterize hits that emerged from a screen, of more than 10,000 compounds from oncology-focused and clinically approved libraries, that showed enhanced cytotoxic effects towards muscle-invasive prostate cancer cell lines, relative to parental and diverse prostate cancer cell models. Several classes of compounds with distinct mechanisms of action were tested in follow-up studies. Additionally, a small collection of oncology-focused agents, which were not included in the initial HTS, were screened for ability to selectively kill the muscle invasive cells.